Center for Testing Potential Anti-Aging Interventions

PROJECT SUMMARY/ABSTRACT
Identification of small molecules that extend mouse lifespan provides new insights into mechanisms of
longevity determination in mammals, and may lay the groundwork for eventual anti-aging therapies in humans.
The NIA Interventions Testing Program (ITP) evaluates agents proposed to extend mouse lifespan by
retardation of aging or postponement of late life diseases. Interventions proposed by multiple collaborating
scientists from the research community are tested, in parallel, at three sites (Jackson Laboratories, University
of Michigan and University of Texas), using very similar, standardized protocols, and using sufficient numbers
of genetically heterogeneous mice to provide 80% power for detecting changes in lifespan of 10%, for either
sex, after pooling data from any two of the test sites. One hundred and two such lifespan experiments,
involving various doses of 66 distinct agents, have been initiated in the first twenty years of the ITP. Thirty-six
experiments have involved comparative tests of multiple doses of effective agents, variable starting ages, or
alternative dosing schedules. Statistically significant effects on longevity, in one or both sexes, have been
documented and then confirmed for NDGA, rapamycin, acarbose, 17-α-estradiol (17aE2), and canagliflozin.
Significant effects were also noted for Protandim, glycine, meclizine, captopril, and astaxanthin. Lifespan trials
are now underway for 25 new agents. ITP survival results have also documented longevity benefits from four
agents started in middle-age: rapamycin, acarbose, 17aE2, and canagliflozin. A Collaborative Interactions
Program (CIP) has provided tissues from ITP drug-treated mice to an open, growing, international network of
scientific collaborators, meeting 26 requests from 17 distinct laboratories in the previous five-year period. Plans
for the next five-year period include additional lifespan ("Stage 1") trials, detailed analyses ("Stage 2") of
agents found to increase lifespan, transition from the CIP to an Interventions Biospecimens Repository,
additional diagnostic specificity in pathological assessments, inclusion of RNA-Seq data in all Stage 2
protocols, and comprehensive pharmacokinetic assessments of drugs found to increase lifespan, as well as
continued collaborative work with a network of scientists to study drug effects on postulated aging mechanisms
and links to disease. Site-specific Stage 2 studies at UT will add pharmacokinetic analyses in young and old
mice, tests to determine mechanisms underlying sex-differences of successful Stage 1 compounds, and tests
to determine effects on metabolism of successful Stage 1 compounds. The work proposed should allow the
ITP to continue to make major contributions to mammalian aging biology.

Public health relevance
PROJECT NARRATIVE The NIA Interventions Testing Program (ITP) represents a multi-site translational research program that tests drugs to see if they increase healthy lifespan in mice as an effective way to discover interventions that may benefit human aging. The work of the ITP 1) yields new insights into the control of aging, aging rate, and age- associated diseases that facilitate the eventual development of agents that could be of benefit in preventive geriatric medicine; and 2) potentially identifies health dangers of unproven treatments that are purported to have anti-aging actions, which will also have public health benefits.